Parental incarceration and the social-emotional health and development of children

PROJECT SUMMARY/ABSTRACT
Significance: Approximately 7% of all US children—and nearly a quarter of Black children—will experience
parental incarceration before age 18, placing them at an increased risk of poor social-emotional development.
Policy-based solutions that increase the economic wellbeing of families involved in the criminal justice system
may offer promise for improving child wellbeing. Individuals with criminal records are less likely to be hired and
often work for lower wages and fewer benefits. As a result, parents with criminal records may have fewer
resources to contribute to establishing their children’s wellbeing. Some states have adopted policies that limit
how criminal records are considered during hiring processes. Protective employment policies could improve
the social-emotional health of children whose fathers have criminal records by increasing paternal employment
prospects and by improving paternal depression via reduced stigmatization of people with records.
Specific Aims: This project will (1) identify the impact of state-level employment policies on the social-
emotional wellbeing of children whose fathers have criminal records, (2) evaluate father’s employment status
and depression as potential mechanisms through which state-level employment policies affect children whose
fathers have criminal records, and (3) assess how the impact of state-level employment policies differs by race.
Approach: The proposed analysis will leverage data from two sources: (1) the Fragile Families and Child
Wellbeing Study, a birth cohort of low-income children in 20 large US cities and their mostly unmarried parents,
and (2) state-level policy information on legal barriers faced by people with criminal records. To account for the
hierarchical design (families nested within states), this analysis will use mixed effects linear regressions to
model the impact of employment policy on child wellbeing. Regression-based mediation analyses will be used
to test potential mediators and stratified analyses will be used to evaluate differential policy effects by race.
Fellowship Information: The applicant is a PhD student in Epidemiology at the University of Minnesota and a
predoctoral trainee on the NICHD-funded T32 training program in Population Health Science. Through
coursework and mentoring on policy evaluation, criminology, and mental health along with guidance on
communicating findings and writing grants, the proposed training plan will build on Ms. Berry’s existing
research skills. This training will enhance her ability to complete her dissertation research and become an
independent social epidemiology researcher with expertise on the impact of social policy on child health.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on evaluating a potential, modifiable policy solution to improve the social-emotional wellbeing of children whose parents are involved in the criminal justice system. If employment policies that protect against criminal record-based discrimination can improve child wellbeing, other policies regulating the consideration of criminal records in domains such as housing and public benefits may also benefit child health and wellbeing. Thus, the proposed research is relevant to NIH’s mission to ensure that all children have the chance to live healthy and productive lives free from disease and disability.